Effect of vocal fold injury on laryngeal muscle dysfunction

ABSTRACT
Voice disorders affect millions of Americans at substantive economic cost. Decisions regarding
treatment are often primarily based on dichotomous thinking: mucosal injury versus muscle dysfunction.
However, laryngeal muscle dysfunction often accompanies laryngeal mucosal pathologies and may be both
causative and reactive. This proposal is an innovative combination of in vivo and in vitro methodologies to
investigate the effect of both transient and persistent vocal fold mucosal injury on the underlying function,
structure, and mechanistic response of the thyroarytenoid muscle, the primary muscle of the vocal fold. The
long-term goal of this research is to provide mechanistic insight regarding the complex interactions between
the mucosal and muscular vocal fold layers, thereby contributing to a shift in clinical schema and classification
of voice disorders, but more importantly, lead to the development of novel, targeted therapeutic strategies for
the millions of patients with voice-related disability. The central hypothesis of this work is injury to the vocal
folds elicits complex interactions between the vocal fold mucosa and underlying muscle, which consequently
results in altered laryngeal muscle structure and function.
The proposed research has two specific aims. Aim 1 is to determine functional, structural, and
mechanistic laryngeal muscle responses to vocal fold injury in an established in vivo rodent model. Two depths
of vocal fold injuries, shallow injury of the mucosa only or deep injury of the mucosa and underlying muscle,
will be created in male and female rats to determine the time course of vocal fold injury on a) muscle function
via analysis of ultrasonic vocalization acoustic complexity, b) mechanistic response of the muscle via
proteomic analysis, and c) changes in specific protein levels identified in the big-data proteomic interrogation.
Injury depths will be confirmed via muscle histology. Aim 2 is to characterize and quantify signaling between
fibroblasts and myoblasts as well as inflammatory cells from the vocal folds in vitro under basal and stimulated
(e.g., injured) conditions. In vitro experimentation will examine the effects of fibrotic and inflammatory
mediators on fibroblasts from the vocal fold lamina propria and myoblasts from intrinsic laryngeal muscle to
interrogate unique interactions between the two cell types via co-culture and conditioned media experiments.
These data will provide critical mechanistic and translational insight regarding the cycle of dysphonia and
provide potential targets for pharmacological interventions.
The proposed research is significant because this foundational mechanistic insight will optimize
treatments for millions of patients with voice-related disability. The proposal is conceptually innovative,
proposes novel, cutting-edge methodologies, and coalesces expertise across multiple laboratories and
specialties.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because understanding the complex interactions between vocal fold mucosal injury and the underlying laryngeal muscle will lead to improved diagnosis and treatment of voice disorders. Thus, the proposed research is relevant to the NIH’s mission and, specifically, to that of the NIDCD to research processes of the disordered voice and improve the life of individuals who have communication impairments.